Defining the role of chromosomal break end synapsis factors for DNA repair

SUMMARY. Clastogenic cancer therapeutics, i.e., agents that induce chromosomal DNA double-strand breaks
(DSBs), such as radiotherapy, remain a cornerstone of cancer treatment. A central aspect of DSB repair is
synapsis of the two DSB ends to mediate repair, such that DSB end synapsis is a potential therapeutic target.
Indeed, one factor important for DSB end synapsis, DNA-dependent protein kinase (DNA-PKcs), is the target of
several inhibitors. This includes M3814/Peposertib (EMD Sereno), which is being tested in clinical trials.
However, at least two other factors, XLF and 53BP1, have also been implicated in DNA end synapsis during
repair. This suggests there may be some redundancy between these factors that could influence response to
inhibitors of DNA-PKcs. In this research proposal, I will investigate the role of end synapsis factors on end joining
(EJ) repair, and the regulation of DNA end resection. Aim 1: Define the role of end synapsis factors on EJ. Aim
1a (Completed): EJ without insertions or deletions (No Indel EJ) is a repair outcome that represents high-fidelity
EJ, which requires factors involved in canonical non-homologous end joining (C-NHEJ), including KU70 and
XRCC4. I sought to define the relative influence of two end synapsis factors (DNA-PKcs and XLF) on No Indel
EJ. I found that DNA-PKcs and XLF promote No Indel EJ, however loss of XLF caused a much greater decrease
in No Indel EJ compared to DNA-PKcs. Importantly, I found that disrupting DNA-PKcs (knockout or treatment
with inhibitor) when combined with XLF mutations that weaken interaction interfaces, caused a synergistic loss
of No Indel EJ. Thus, the conclusion of my published study is that the role of DNA-PKcs is magnified to promote
No Indel EJ when XLF is weakened. Aim 1b (F99 Phase). Building on these findings, I will investigate another
end synapsis factor, 53BP1. Specifically, I will address the hypothesis that 53BP1 has a partially redundant role
with DNA-PKcs and XLF to promote chromosomal EJ. In performing this research, I will expand my skill set in
several ways, including learning to assess EJ outcomes using different computational approaches from the
completed research. Aim 2 (K00 Phase). In the postdoctoral phase of the research proposal, I will be assessing
the role of synapsis factors on cleaving of DNA ends bound to DNA-PKcs to initiate end resection. End resection
is the first step of homology-directed repair, and is mediated by the MRN/CtIP nuclease complex. Recently,
MRN/CtIP was shown to cleave DNA ends bound to DNA-PKcs, which may be the key initiating step of end
resection. I propose to test the hypothesis that disruption of end synapsis causes an increase in this initiation
step of end resection, which I will test with several techniques that will expand my research skill set. Altogether,
these studies will fill a major gap in our understanding of the role of end synapsis factors on the regulation of
DNA DSB repair mechanisms. Such research is significant for developing end synapsis as a target for cancer
therapy, including identifying the ideal circumstances to apply inhibitors of DNA-PKcs (e.g. M3814/Peposertib)
during cancer treatment.

Public health relevance
NARRATIVE. Clastogens (i.e., chromosomal-breaking agents), including ionizing radiation, remain a cornerstone of cancer therapy; however, their efficacy could be improved by inhibiting chromosomal break repair in cancer cells. A central step of such repair is synapsis of chromosomal break ends, and indeed inhibitors of an end synapsis factor, the DNA-dependent kinase catalytic subunit (DNA-PKcs), are being tested in clinical trials; but to identify the ideal contexts for using such inhibitors, it is critical to understand the mechanism of chromosomal break end synapsis. Thus, our proposed studies to elucidate the mechanisms of chromosomal break end synapsis during DNA repair will support the mission of the NIH to improve cancer treatments and patient outcomes.